Blood Flow Regulation and Neuromuscular Function Post-Stroke

Increased neuromuscular fatigability (the acute, exercise induced reduction in force) is an understudied
consequence of stroke. This is a clinically meaningful area of study because increased neuromuscular
fatigability can negatively affect task endurance for activities like walking, and successful rehabilitation strategies
require repeated levels of muscle activation and overload to cause functional gains in motor performance. In
addition to decreased neural drive to motorneuron pools, recent data indicate that reduced blood flow to
exercising paretic muscle may play a significant role in increased neuromuscular fatigability. Exercising muscles
require adequate blood flow to match the increase in metabolic demand, and we have shown that stroke
survivors have reduced blood flow to the leg muscles during exercise. During exercise, sympathetic nervous
system activity increases in an activity-dependent manner, causing vasoconstriction in inactive muscle beds. In
the active muscle, the release of local vasodilatory factors counteracts sympathetic vasoconstriction to maintain
vascular tone. This process, called functional sympatholysis, has been postulated to be critical to muscle
perfusion during exercise. Our central hypothesis is that in people with stroke functional sympatholysis is
impaired and results in dysregulated blood flow during exercise, which exacerbates neuromuscular fatigability
and limits motor function. We propose three specific aims. In Aim 1 we will establish impaired functional
sympatholysis in chronic stroke survivors and determine the relationship with metrics of neuromuscular fatigue.
We will test two hypotheses in Aim 1: 1) that functional sympatholysis during exercise is impaired in the paretic
leg of chronic stroke survivors compared to the non-paretic leg and age- and sex-matched controls, and 2) stroke
survivors with the highest degree of functional sympatholysis impairment will have greater paretic leg muscle
fatigability, and both impaired modulation of motor unit firing rates and increased metabolite buildup in the muscle
during exercise. In Aim 2 we will interrogate microvascular (dys)function in the lower extremity of chronic stroke
survivors. We will test two hypotheses in Aim 2: 1) that compared age- and sex-matched controls, chronic stroke
survivors will have reduced nitric oxide-mediated vasodilation to acetylcholine and an enhanced vasoconstrictor
response to locally infused norepinephrine, and 2) that maximum dilation to acetylcholine in the affected leg will
be positively associated with lower paretic muscle fatigability. Finally, in Aim 3 we will determine if a non-invasive
intervention called ischemic conditioning (IC), which is known to improve muscle performance and vascular
endothelial function, can improve functional sympatholysis, and if improvements in functional sympatholysis are
associated with reduced paretic muscle fatigability. We will test two hypotheses in Aim 3: 1) that IC causes
immediate and sustainable improvements in functional sympatholysis, and 2) that IC-induced improvements in
functional sympatholysis are associated with improved muscle fatigue resistance, and both greater modulation
of motor unit firing rates and less muscle metabolite buildup during fatiguing contractions.

Public health relevance
Project Narrative The muscles of stroke survivors can fatigue faster compared to muscles in people who have not had a stroke, which can limit how long a person with stroke can perform tasks such as walking. This study will examine how blood flow is regulated to the exercising leg muscle post-stroke, because if the muscle does not receive enough blood flow it will become fatigued. Finally, we will use a safe and simple non-invasive intervention called ischemic conditioning, which has known effects to improve blood flow to exercising muscle and determine the effects on muscle fatigue.